Career Development in Pediatric and Medical Oncology

PROJECT SUMMARY/ABSTRACT
We are requesting funds for The Paul Calabresi Career Development Award for Clinical Oncology in Pediatric
and Medical Hematology/Oncology at the Fred Hutchinson Cancer Research Center, University of Washington
School of Medicine and Seattle Children’s Hospital. The Career Development Program will interface with our
Pediatric Hematology/Oncology, Medical Oncology, and adult Hematology Training Programs at the Fred
Hutchinson Cancer Research Center and the Departments of Pediatrics and Medicine at the University of
Washington, with the goal of developing and supporting transition of clinical translational investigators into
independent investigators. This K12 Career Development Award for Clinical Oncology will be an integral part
of our program towards grooming the next generation of independent clinical researchers by supporting four
physicians each year who have completed fellowship training in the pediatric or medical hematology/oncology
training programs with track record of promising independent clinical/translational careers. Prior to entry into
the program, scholar candidates will have acquired clinical skills and basic laboratory tools of modern biology
and translation of laboratory findings to clinical application. Those most qualified and motivated to enter into
investigative endeavors in clinical translational research will be selected.
The K12 scholars will receive two to three years of funding to help develop requisite experience to conduct
clinical translational research, translate their findings to patients, and generate sufficient data to help establish
independent research careers. The aim of their projects will be to contribute new and useful information
relevant to clinical oncology and to develop the clinical research capabilities of the trainees. The supported
research projects include those in the areas of hematopoietic stem cell transplantation, immunology and
immunotherapy, transplantation biology, outcome and quality of life research, malignant hematopoiesis, human
immunogenetics, and programs in solid tumor research including tumors of the brain, breast, ovaries, prostate,
and breast. Additional projects in molecular biology and gene therapy, as well as other relevant research
arenas, will be available. Trainees will also gain experience in clinical protocol development, conduct, and
evaluation, and will receive didactic training in biostatistics, clinical trial design and biomedical research
integrity.
This program utilizes the laboratory and clinical research facilities of the Fred Hutchinson Cancer Research
Center, the University of Washington, and the Seattle Children’s Hospital Research Institute, and the clinical
facilities of the Seattle Cancer Care Alliance, The University of Washington, and the Seattle Children’s
Hospital.

Public health relevance
Project Narrative The aim of the Pediatric and Medical Oncology Career Development Program is to provide physicians with the tools and experience necessary to conduct clinical research, translate their findings to patients, and generate sufficient data to help establish independent research careers. Trainees will contribute new and useful information relevant to clinical oncology.